Pediatric Latent HIV Reservoir Characterization and Quantification Assay

PROJECT SUMMARY ABSTRACT
Public Health Problem
Modern antiretroviral therapy (ART) combinations greatly improve survival of HIV infected individuals and reduce
HIV transmission. However, there are still 38 million people living with HIV (PWH) worldwide and of those 1.8
million are children under the age of 15, highlighting the imperative need for curative therapies. In limited
resource areas, where pediatric HIV is most common, the use of new assays that require less blood volumes,
lower cost and less labor-intensive methods are necessary to facilitate clinical trials aimed at reducing the size
of the latent reservoir and/or to achieve a cure or ART-free remission.
The ultimate value of the SBIR Phase I project will demonstrate the ability of our technology to characterize and
quantify the pediatric HIV-1 reservoir, which remains a critical unmet need in the HIV cure field.
Issues with Current Solutions & How Product Meets Unmet Needs
RNAamp allows direct detection of RNA, which provides the most accurate measure of the HIV replication
competent reservoir. The assay is proven to be faster and have better reliability and quantification than HIV
reservoir assays based on QVOA, RT-qPCR, RT-ddPCR, iSCA and IPDA. RNA target amplification and
detection is accomplished by oligonucleotide-templated photoreduction using short, sequence-specific
profluorophore and catalytic probes. Reproducibility is outstanding (4% variance between replicates) and Limit
of Detection (LoD) is 1 HIV-infected cells/1 x 106 PBMCs or 1-10 RNA copies/mL, using a standard blood draw
(10-30 mL).
Jan Biotech’s RNAamp quick, direct RNA test, with its use of small blood samples, ease of sample preparation,
reliability and sensitivity, quantitative ability and short time to result, is ideally suited for characterization and
quantification of the rebound-competent pediatric HIV reservoir.
Summary of Approach
Jan Biotech has developed an assay with a prediction accuracy of 0.92 for time to rebound after treatment
interruption for early/acute-treated adult participants. The assay, RNAamp, utilizes nonezymatic, chemical
amplification of cell-associated HIV RNA targets to provide quick, sensitive, and quantitative measurement of
the HIV reservoir. No other assay, including QVOA, IPDA, iSCA, RT-qPCR, or RT-ddPCR, provided a prediction
accuracy of greater than 0.2 for the same adult participants. This proposal is to develop RNAamp for cross-
subtype (i.e., non-B subtype) HIV reservoir detection, specifically for pediatric testing, for which the use of small
samples easily tested by RNAamp is crucial. Pediatric HIV-infected individuals are typically treated during early
HIV infection, often treated at birth, and physician-monitored or spontaneous treatment interruption is more
frequent in this population. Pediatric treatment efficacy and treatment interruption clinical trials typically include
non-B subtype HIV-infected participants.
Collaborators and Unique Resources
Jan Biotech, Inc., with expertise in molecular diagnostic development, will consult with Jonathan Li, MD, MMSc
Assistant Professor of Medicine, Harvard Medical School, in a AIDS Clinical Trials Group (ACTG) study and
Harris Gelbard, MD, PhD, University of Rochester Medical School.
Phase I Specific Aims
Specific Aim 1: Develop HIV-1 cross-subtype (CS) RNAamp multiplexed assay
Specific Aim 2: Correlate CS-RNAamp to Pol RT-qPCR using non-B subtype HIV-infected cells
Specific Aim 3: Pediatric human sample testing using CS-RNAamp HIV reservoir characterization
Market after Phase II Completion
Both Gilead and Merck are commercially interested in the technology. Regulatory approval will be sought for
commercialization.

Public health relevance
Project Narrative - Relevance to Public Health Modern antiretroviral therapy (ART) combinations greatly improve survival of HIV infected individuals and reduce HIV transmission. However, there are still 38 million people living with HIV (PWH) worldwide and of those 1.8 million are children under the age of 15, highlighting the imperative need for curative therapies. In limited resource areas, where pediatric HIV is most common, the use of new assays that require less blood volumes, lower cost and less labor intensive methods are necessary to facilitate clinical trials aimed at reducing the size of the latent reservoir and/or to achieve a cure or ART-free remission.